BLRD Research Career Scientist Award Application

Abstract
The main focus of our scholarly work has been conducting laboratory-based research into
aging-relevant neurodegenerative diseases with a particular focus on neurodegenerative
diseases impacting Veterans’ health. We have established a group of interdisciplinary
researchers to identify genes and pathways involved in aging-related neurodegenerative
disease for the purpose of developing small-molecule neuroprotective agents for
neurodegenerative diseases impacting Veterans’ health. In particular our group
investigates the molecular targets for intervention against tau and TDP-43 neurotoxicity
in neurons. For this approach we employ a variety of model systems including transgenic
C. elegans, transgenic rodent, and human cellular models of protein aggregation. These
models are used to uncover genes playing a conserved role in neurotoxicity. We
anticipate that work in model systems may provide insight into mechanisms of
neurodegeneration in human disease. We can thus use these findings to formulate
hypotheses of neurotoxicity and develop neuroprotective strategies accordingly. Our
ultimate goal is to validate neuroprotective strategies using mammalian systems to de-
risk future development of therapeutic approaches for conditions impacting Veteran’s
health with a particular focus on Alzheimer’s disease and ALS (a service connected
condition).

Public health relevance
Narrative Statement To date, few clinical trials for tauopathy have specifically targeted pathological tau, yet neurofibrillary tangles are the diagnostic neuropathological hallmark of AD and CTE that is most closely associated with cognitive decline. To help fill this gap, we propose to develop novel neuroprotective strategies that target pathological tau in AD and CTE related dementia disorders. Specifically, we propose to develop therapeutic ideas for targeting pathological tau. These novel agents will provide a proof-of-concept demonstration that inhibiting targeting pathological tau deposition can improve neurodegenerative outcomes.